Nuclear Events in PTHR1 Action on Bone

Parathyroid hormone (PTH) is an essential regulator of calcium homeostasis and became the prototypic
osteoanabolic hormone for treating osteoporosis. On the other hand, hyperparathyroidism, with its consequent
bone breakdown, is a major problem in and of itself and in chronic renal failure. The hormone acts through its
G-protein-coupled receptor on the osteoblast to elicit enhanced bone resorption by the osteoclast. To do this,
the osteoblast produces receptor activator of nuclear factor kappa-β ligand (RANKL) in response to PTH.
RANKL is widely considered a principal mediator of PTH-induced bone catabolism and has been associated
with bone loss in hyperparathyroidism. Our work in the last cycle of this grant revealed that PTH activates
cAMP/protein kinase A (PKA) to inhibit salt-inducible kinases (SIKs) and requires protein phosphatases (PPs) to
stimulate Rankl expression in osteoblasts. Knockdown of salt-inducible kinases (SIKs) 2 and 3 and cAMP-
regulated transcription coactivators 2 and 3 (CRTC2 and 3) indicate that all four are part of this pathway.
Moreover, inhibition of serine-threonine protein phosphatases decreased both PTH-induced Rankl expression
and the stimulation by PTH(1-34) of CRTC2 and 3 translocation into the nucleus. Upon entry into the nucleus,
these CRTCs associate with unknown basic leucine zipper domain (bZip) transcription factor(s), activating
Rankl transcription through binding to its distal PTH-responsive cAMP-response elements (CREs). From these
data of cells in culture and preliminary data in vivo, we have developed the central hypothesis that SIK/PP
regulation of CRTC2/3 is essential to their function in the skeleton, and PTH controls this regulation. The long-
term goals of this work are to delineate the signaling and transcriptional regulatory mechanisms conveying
PTH action in bone. Consequently, the specific aims to test our hypothesis of this resubmitted competing
renewal proposal focus on the SIK and PP regulation of CRTC2/3 function and action on Rankl, and will, 1)
determine the mechanism of PTH regulation of Rankl transcription in osteoblasts by a. elucidating the
regulatory mechanisms involved in CRTC2/3 nuclear translocation in osteoblasts, b. identifying the bZip
transcription factor(s) responsible for CRTC2/3-induced Rankl transcription, 2) determine the role of CRTC2/3
in bone development and PTH’s anabolic and catabolic effects by a. determining the site and role of osteoblast
CRTC2/3 in bone development, b. ascertaining the effects of deletion of CRTC2/3 on PTH’s anabolic and
catabolic actions in bones of adult mice. The results of this work will make major contributions to our
knowledge of how PTH exerts its nuclear effects on skeletal function through the SIK/PP/CRTC/bZip pathway.
In so doing, the data will also provide new perspectives into treatment of disorders of calcium metabolism and
other severe diseases functioning through the PTHR1 pathway such as Jansen’s metaphyseal
chondrodysplasia and McCune-Albright syndrome.

Public health relevance
This research will investigate how a protein hormone (parathyroid hormone, PTH) is able to interact with the surface of a cell in bone and transmit signals to the cell's DNA to regulate the expression of genes involved in bone breakdown. PTH is essential for maintaining serum calcium levels, but too much of the hormone or genetic diseases that act like PTH can cause major bone loss and disabilities. The results of our research will help develop treatments for hyperparathyroidism and other bone and skeletal disorders in place of surgery.